Symptoms Assessment and Screening for Laryngeal Injury Post-extubation in ICU

PROJECT SUMMARY
Globally, each year 13 - 20 million people become critically ill and are intubated with mechanical ventilation in
an intensive care unit (ICU). In the U.S. alone, there are approximately 1 million intubated, with nearly one-third
for >5 days. As many as 73% of these patients will sustain laryngeal injury within 1 day of endotracheal tube
placement. For >50 years, research has demonstrated a strong association between endotracheal intubation
and laryngeal injury, but without considering the role that patient symptoms may play in identifying such injury.
Research in laryngeal injury and voice/communication is a research priority among several professional
societies, including the American Association of Critical Care Nurses and the Society of Critical Care Medicine.
After extubation, patients often have a range of symptoms related to laryngeal injury and voice changes, including
hoarseness, loss of voice, throat clearing, sore throat, and vocal fatigue. At present, patients with such symptoms
are not identified as being high-risk for laryngeal injury and are often overlooked with the thought that their
symptoms will be self-limited. Such a “wait and see” approach to laryngeal injury may defer evaluation for 1 week
to 3 months (or longer). Unfortunately, this approach has resulted in some patients experiencing serious, long-
term consequences, with some injuries resulting in chronic conditions that may have been avoidable with early
evaluation and appropriate intervention. Hence, early identification is important, but there is no standard of
practice for referral to a speech-language pathologist or laryngologist after extubation for evaluation. The existing
literature has important weaknesses, including patient samples that are heterogeneous, poorly described, and
often small-sized. In recent years, clinical practice and associated guidelines have changed to target patient
wakefulness during intubation with mechanical ventilation, creating a new and important opportunity to interact
with patients to evaluate their symptoms during intubation and soon after extubation. Therefore, the overall goals
of this research are to systematically: 1) determine patient symptoms related to orotracheal intubation, both
during and after intubation, 2) evaluate laryngeal injury and voice function after extubation using advanced
methods of laryngoscopy and perceptual and acoustic voice analyses, and 3) construct a screening tool, based
on patient and ICU variables and patient symptoms, to assist in identifying patients with clinically important, post-
extubation laryngeal injury. This systematic evaluation of patient symptoms, combined with comprehensive
laryngoscopic and voice assessment, will inform the development of a clinical screening tool for use by clinicians
in the ICU with the aim of appropriately identifying patients needing further evaluation to reduce the short- and
long-term harms of endotracheal tube-related injury on the larynx and voice.

Public health relevance
NARRATIVE Placing a breathing tube to provide mechanical ventilation (artificial respiration) for life support in the intensive care unit (ICU) is essential for survival, but results in damage to the voice box and airway. This study aims to systematically evaluate patient symptoms in order to develop a screening method for use in the ICU. The new knowledge generated by this project will help shift clinical practice in ICUs by using patient symptoms to help identify those who may need specialized evaluation to reduce serious, long-term complications after having a breathing tube as part of their life support in the ICU.